Biostatistics and Data Management Core

Abstract:
The Biostatistics and Data Management Core (BDMC) of the East Africa Consortium for HPV and Cervical
Cancer (EACHC) is a shared resource for study design, research collaboration and the collection, management,
sharing and analysis of all data generated from all constituent research projects in the Consortium. The BDMC
will provide a space for research collaboration for all investigators, enable rigorous study design and offer
expertise in the collection, validation, sharing and analysis of all data generated in each project. The BDMC will
also facilitate the protection of human subjects by developing and deploying secure hardware and software
solutions for storage and transmission of data containing private health information. In conjunction with the
Developmental Core, we will offer opportunities for training and mentorship in data collection, management and
analysis.
The BDMC, which is embedded in the Regional Data Center of the East Africa Regional Consortium of the
International Epidemiology Databases to Evaluate AIDS (IeDEA), will use its expertise with advanced analytical
methods and management of data generated from multiple programs, hardware and software platforms and
countries in the region to accomplish the following three inter-related Specific Aims:
Specific Aim 1: Provide statistical leadership in study design, data analysis and presentation of results for all
projects proposed by the Consortium.
Specific Aim 2: Offer informatics and data management expertise in the collection, harmonization, validation,
integration and overall management of data generated by all research projects proposed in this application.
Specific Aim 3: Serve as focal point for mentorship and training in informatics, data management and analysis
for all members of the Institute, build technical and research capacity in informatics and statistics and develop a
culture of rigorous study design, experimentation and reproducible research.
Through these efforts, the BDMC will enable a culture of openness, sharing and reproducible research by
developing operating procedures for collection, management, secure storage of research data and archiving of
data and analysis software and will contribute to capacity building in the region by providing training and
education with respect to study design and data literacy

Public health relevance
Narrative The Biostatistics and Data Management Core (BDMC) will leverage decades-long experience with collecting, harmonizing, validating, combining and analyzing data from multiple countries, programs hardware and software platforms in East Africa, and longstanding collaborations with investigators and institutions in the region, through the East Africa Regional Consortium of the International Epidemiology Databases to Evaluate AIDS (IeDEA-EA).